Advancing Antimicrobial Use Measurement in U.S. Companion Animal Practice

Project Summary
Antimicrobials are critical for animal and human health, but antimicrobial resistance (AMR) is a threat to their
continued effectiveness. Antimicrobial use (AU) is a modifiable risk factor for the emergence and spread of
AMR, and tracking AU is needed to improve prescribing. Logistical challenges to AU measurement in the
veterinary field include access to prescribing data held within diverse mutually exclusive electronic health
record (EHR) systems and lack of standard diagnostic coding. The Companion Animal Veterinary Surveillance
Network (CAVSNET), a successful public-private partnership that collects, analyzes, and reports companion-
animal veterinary data, overcomes these obstacles through the compilation of non-standardized patient-level
data into a standardized common data model (CDM). CAVSNET fulfills a critical need in the fight against AMR,
providing data on AU at the point of use (i.e., veterinary clinics) to connect the clinical context, such as disease
process, diagnostic tests, and patient demographics, with prescription data. In addition to discrete data fields,
unstructured free-text data are available for classification with NLP-PIER, a natural language processing (NLP)
platform that enables named-entity recognition and indexing in a secure computing environment; these notes
can be mapped to structured categories for analysis. Point-prevalence survey (PPS) methodology, which relies
on detailed manual review of medical records, is structured to collect standardized data from multiple sites over
a specific period of time; PPS are used to provide granular data and augment automated CAVSNET data
collection to better understand the complexities of relating AU data to clinical condition. The overarching goal of
this project is to harness data from CAVSNET and complementary PPS to analyze AU for dogs, cats, and
horses and provide actionable targets for antimicrobial stewardship. Longitudinal AU tracking provides
information needed to target prescribing improvement interventions, can be used to motivate practitioners to
change behaviors, and show the profession's progress over time. CAVSNET's public-private partnerships for
ongoing and long-term data collection will 1) characterize and address AU data gaps, 2) collect, standardize,
and provide annual summaries of AU data, including contextual information and data trends, while maintaining
veterinary and client confidentiality, 3) share data with the veterinary community and the public, and 5) use a
common data model that lends itself to interoperability. It will provide a comprehensive picture for U.S.
companion animals by 1) providing yearly national estimates of systemic antibiotic use prevalence in
companion animal practices, including contextual demographic information, using CAVSNET, 2) generating
U.S. estimates of systemic antibiotic use for specific clinical conditions via CAVSNET, and 3) characterizing
antibiotic use data gaps in companion animal practice and utilizing methods to address gaps, including NLP-
PIER and national AU PPS for horses and select surgical procedures in dogs and cats.

Public health relevance
Project Narrative Improved understanding of antimicrobial usage patterns in companion animals is needed to support efforts to mitigate antimicrobial resistance—a growing global health threat. The project will provide actionable targets for antimicrobial stewardship by 1) harnessing data from the Companion Animal Veterinary Surveillance Network, a successful public-private partnership that collects, standardizes, and analyzes veterinary electronic health data from over 1,300 U.S. clinics and 2) performing targeted point-prevalence surveys of antimicrobial use in dogs, cats, and horses. The findings could inform evidence-based policy changes and strengthen surveillance systems, ultimately enhancing public health outcomes.